EFFICACY AND DESIRABILITY OF AUTOGENIC DRAINAGE WITH CHEST PHYSIOTHERAPY

The safety, efficacy, and desirability of traditional chest physiotherapy will be compared with autogenic drainage technique of chest therapy in 30 subjects with cystic fibrosis, age 8 to 35 years. A cross-over design utilizing one month of each therapy will be used. Parameter os pulmonary function, basal metabolic rate, sputum production, and quantitative cultures will be assessed and compared.